Center for Human Genome Reference Diversity

ABSTRACT
This project represents Phase II of the Human Pangenome Project, a global high-quality resource of human
genetic diversity. We aim to expand our collection of human reference genomes from 350 to 550 by prioritizing
an additional 200 samples, employing advanced technology for accurate, telomere-to-telomere (T2T) genome
sequencing, and ensuring the ethical handling of all research stages, ultimately supporting the broader
genomics research community with an improved pangenome resource. In Aim 1, the Genomes Center will
direct the selection of new samples from prospective recruitment that are properly consented for open-access
unrestricted use and lymphoblastoid cell line establishment. In Aim 2, we will augment the current pangenome
reference by producing high-coverage genomic datasets and assembly workflows necessary to routinely reach
finished, T2T genomes. We will do so using a novel combination of sequencing technologies and algorithms
that we and others developed to produce the highest quality and most complete genome assemblies to date.
We will optimize quality and cost-effectiveness iteratively. All outputs, including protocols, software tools, and
quality standards will be made accessible via the NHGRI Genomic Data Science Analysis, Visualization, and
Informatics Lab-space (AnVIL) and other resources. In Aim 3, the Genomes Center will engage a team of
Ethical, Legal, and Social Implications (ELSI) scholars to identify, address, and develop solutions for key
ethical and social issues such as consent, data release, and resource equity. This fully integrated ELSI team
will actively participate in decision-making processes, engaging underrepresented groups in pangenome
projects. Our Genome Center will be committed to efficient project management and consortium collaboration
to ensure the timely completion of all activities. We aim to focus on the generation of a human pangenome
reference that optimizes representation of genetic diversity and encourages its use by the genomics research
community. To achieve these aims we have assembled an exceptional team consisting of leaders from around
the world in consent ethics, sample collection, sample extraction, and high-quality genome sequencing,
assembly, finishing, evaluation and annotation. The team also has expertise in using genomic technologies to
address a broad range of scientific questions, so is highly cognizant of the practical needs of biomedical
researchers who will use this resource. The produced high-quality genomes will be curated and released by
our Genomes Center, thereby contributing to the Human Pangenome Reference Resource. Its completion will
be essential to the future of precision medicine to ensure that all people, regardless of ancestry, are able to
benefit from the promise of genomic medicine.

Public health relevance
PROJECT NARRATIVE The Genome Center will lead the prioritization, recruitment, and selection of samples from study participants representing global diversity consented for open access data release. With those samples, we will produce 200 new, very high-quality haplotype-resolved, and annotated, human genome assemblies for inclusion in the human pangenome reference resource. We propose to complete this work with a team of ethical, legal and social implications (ELSI) scholars who will be embedded in our effort.